The Role of Interlocutor Behavior on Code Switching Patterns in Bilingual Children with and without Developmental Language Disorders

PROJECT SUMMARY/ABSTRACT
Code-switching (alternation between language in a single utterance) is a common phenomenon observed
among bilingual children with typical and atypical language, including children with developmental language
disorder (DLD). Code-switching requires the speaker to integrate morphosyntactic features in both languages;
therefore, language proficiency and social factors are important factors to consider when analyzing code-
switching patterns. Current research on code-switching in children with DLD is limited by methodological
issues, including problems with coding approaches, elicitation tasks, and accounting for children's language
development. To address these issues, this proposed study will use a comprehensive coding method and a
conversational elicitation task to examine code-switching patterns in bilingual children with and without DLD.
The study will consider two perspectives, linguistic and sociolinguistic, to understand how language ability
interacts with this phenomenon. The study will involve a Diapix task with three different interlocutors (English-
only, Spanish-only, and bilingual Spanish-English). The conversations will be recorded, transcribed, and
coded. This study aligns with the National Institute of Health's (NIH) vision and mission statement of seeking
fundamental knowledge to advance diagnostic practices for clinicians working with bilingual Spanish-English
speaking children globally. Ultimately, this project aims to provide essential and innovative research in the area
of bilingual language disorder, while also training a promising new investigator in ethical, methodological, and
substantive research practices.

Public health relevance
PROJECT NARRATIVE A striking characteristic of bilingual speakers is code-switching (alternating two languages within a single discourse) to meet pragmatic and/or linguistic needs. Prior research has explored the grammatical constraints and sociolinguistic aspects of code-switching independently. However, few have examined how these constrain may interact to influence differences in code-switch patterns between children with and without developmental language disorder. Therefore, the proposed research will investigate the sociolinguistic characteristics (interlocutors, language proficiency and language ability) among bilingual children with and without language disorder. The objective is to enhance the theoretical foundation and gain deeper insights into the code switching behaviors of bilingual children as they learn to navigate between two languages.